Personalized Cystic Fibrosis Therapy and Research Center

PROJECT SUMMARY – OVERVIEW
Cystic Fibrosis results from the absence or dysfunction of the Cystic Fibrosis Transmembrane Conductance
Regulator (CFTR) chloride channel. Defects in CFTR are strongly associated with genetic variations in the CFTR
gene that are unique to individual CF patients or to subgroups within the CF patient population. Thus, a
personalized medicine approach helps customize care to individual CF patients based on the unique molecular
and phenotypic characteristics associated with their CFTR gene. In this renewal application we will promote
clinical, translational, and basic research collaboration to improve CF therapy and patient quality of life through
personalized medicine with an emphasis to address CF minority population. This goal will be achieved through
3 integrated cores: Personalized Clinical Core, Personalized Model Systems Core and the new CF-Organ-on-a
Chip Core. This will drive successful therapeutic outcomes and minimize potential adverse effects of chronic
therapies. Given that the largest benefit of highly effective modulators is on lung function with little tangible effect
on CF related diabetes, the focus of the CF-Organ-on-a Chip Core will be the study of mechanisms of diabetes
in ductal and endocrine pancreatic cells lacking CFTR in multiple genetic mutations. We will leverage an IRB
approved genotype-phenotype database available for clinical and research use, to develop Personalized Cystic
Fibrosis Therapy and Research Center (PCFC) for individual patients to (i) determine his/her susceptibility to a
particular form of CF mutation, and ii) take steps to mitigate the early onset of the disease. Finally, the future of
CF research offers the potential for a variety of CFTR-targeted therapies (i e., CFTR modulators) to treat the
underlying cause of CF, with multiple modulators currently in different stages of development.

Public health relevance
PROJECT NARRATIVE Our Cystic Fibrosis (CF) Center at Cincinnati Children’s Hospital Medical Center (CCHMC) already has an excellent electronic medical record system (EPIC) and a site-specific IRB approved genotype database available for clinical and research use. We intend to leverage these capabilities to develop Personalized Cystic Fibrosis Therapy and Research Center (PCFC) for individual patients to determine his/her susceptibility to a particular form of CF mutation, and take steps to mitigate the early onset of the disease.